Asthmatic inflammation requires neuronal upregulation of B-cells

Project Summary
Asthma and asthmatic symptoms continue to persist and are a growing health burden demonstrating the need
to understand how the main asthmatic effector molecule, immunoglobulin (Ig) E (IgE), is produced. Asthmatic
pathology occurs by IgE being produced in response to what are typically innocuous substances. While IgE
production can lead to protective immunity in response to venoms and multicellular pathogens, its overproduction
in response to benign substances underlies its role in asthmatic and allergic inflammation. IgE is secreted from
B lineage cells in the presence of cognate antigen and activates mast cells and basophils to release potent
inflammatory molecules which act directly on the airway wall and attract inflammatory cells to the lungs. Emerging
evidence demonstrates that allergic inflammation sensitizes another cell type- neurons. Once sensitized,
neurons release a host of neurotransmitters which enhance allergic inflammation, and recent data indicate the
neuronal ability to enhance B-cell mediated IgE overproduction. However, what sensitizes these neurons and
what effect sensitized neurons have on asthmatic pathology, in particular the overproduction of IgE, requires
further investigation.
The overall objective of this application is to investigate the role of the sensory and autonomic neurons in IgE
overproduction in allergic asthma. Our preliminary data has led us to hypothesize that sensory neurons
stimulate sympathetic neurons to stimulate B-cell overproduction to increase IgE release. We show that
sensory neurons can sense antigen alongside antigen-sensing immune cells. This stimulation of sensory
neurons by antigen then increases B-cell production by eliciting sympathetic reflex activation. Once the surplus
B-cell reservoir reaches the allergic lung, stimulated sensory neurons then release their neurotransmitters during
antigen recognition which stimulates the overproduction of IgE. We will investigate this novel neuronal circuit of
IgE overproduction in two aims. Studies in AIM 1 will use robust electrophysiological recording and calcium
imaging techniques to assess a novel signaling pathway of sensory neuron antigen recognition, excitation, and
hypersensitization. Subsequent molecular assays will delineate the exact downstream molecule effector with the
hopes to identify potential drug targets for future study. Studies in AIM 2 will use neural tracer technology to
learn which brain regions are involved in this novel neuronal circuit. Further studies in this aim will test the
necessity and sufficiency of sensory neurons and autonomic neurons in regulating B-cell production using state-
of-the-art chemogenetic tools. Isolated cell experiments will delineate which neuronal molecules affect B-cell IgE
production. These data will drive further experiments to identify how the entire pathway works in a mouse model
of fungal allergic asthma. This contribution is significant because it is expected to elucidate a complete
picture of how IgE is produced and dysregulated in asthma. Such knowledge has the potential to inform
the development of new strategies that will help to reduce the growing problem of allergic asthma.

Public health relevance
Project Narrative This proposal aims to investigate immunoglobulin E overproduction by the sensitization and reflex augmentation of sensory neurons and efferent autonomic nervous system activation. The proposed research is relevant to public health because a better understanding of the complete neuro-immune landscape and its dysregulation with fungal asthma will increase understanding of fundamental mechanisms involved in allergic/asthmatic pathology, of which immunoglobulin E is at its core. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge that will help reduce the burdens of human disability.